Thalmocortical interactions in taste perception

PROJECT SUMMARY
Cortical taste responses reflect sensory stimulation, perception, and behavioral decisions. These responses
are the result of interactions among several brain areas. Ascending signals from the thalamus provide
information from the periphery, but there are also recurrent interactions among several forebrain areas,
including massive descending feedback connections to thalamus. Using this circuitry, animals must rapidly
decide whether they will consume or expel a substance applied to the tongue. This behavior is natural,
requires no training, and has obvious behavioral correlates that reflect the consumption or expulsion decision.
Understanding how multiple brain areas interact to produce responses, perception, and behavior is a major
goal of systems neuroscience, and the gustatory system is well suited to this pursuit. Recent work from a
number of labs has gone far to characterize the nonlinear population dynamics of cortical taste activity, and
has begun to unravel the inter-regional interactions that generate said dynamics, most notably with regard to
the basolateral amygdala (Lin, et al., 2021; Mahmood, et al., 2023). Thalamo-cortical interactions have been
slower to yield to scrutiny, however, because of the intense difficulty of even recording from taste thalamus in
awake animals—something that has only been done a few times (e.g., Liu and Fontanini, 2015).
We propose to explore the relationship between ensemble activity in the gustatory thalamus and ensemble
activity in the gustatory cortex. There have been few studies of physiological responses in gustatory thalamus,
and no studies where gustatory thalamus neurons have been recorded simultaneously with gustatory cortical
neurons. New methods using high-density silicon electrodes now allow action potentials of afferent neurons
and local neurons to be distinguished, allowing thalamic axons and cortical neurons to be recorded at a single
site in the cortex. We will validate and employ these methods to simultaneously record thalamic and cortical
neurons in the gustatory system of awake behaving rats during taste deliveries followed by consumption or
expulsion. By examining these structures in a system with tight linkages between cortical activity and behavior,
we expect to uncover new principles of interaction between thalamus and cortex.

Public health relevance
Project Narrative When a taste is placed on our tongues, we must recognize that a taste is on the tongue, identify that taste, decide whether it’s palatable or not, and then either swallow it or expel it. These processes require integration of information about taste from the periphery, which is relayed to the taste cortex, in part through the gustatory thalamus, though it is unclear how thalamus and gustatory cortex interact to produce activity in gustatory cortex that reflects stimulus identity and palatability, which we will study here. These results will increase our understanding of taste that will help us fight against a spectrum of feeding-related disorders.